Control of cellular resource allocation across biological scales in microorganisms

Project Summary
Homeostasis is a fundamental feature of physiological control in all cells. In the past ﬁve years, a new
homeostatic principle co-discovered by us has been changing our view of cell-size control. This principle,
known as the “adder”, states that cells add ﬁxed size between birth and division irrespective of the cell size at
birth. The adder principle is therefore distinct from many biological controls due to its passive nature, as the
adder-like cells do not employ any apparent size sensing or feedback mechanisms to trigger division when
they reach a ﬁxed critical size. The proposed program is an extension of our success in cell-size control
research to understand a broader class of physiological controls.
First, we will study the mechanisms responsible for the precision and robustness of physiological processes.
We will focus on replication initiation in bacteria as it can serve as a tractable model to solve these long-
standing problems. Another important aspect of physiological control is how cells allocate their resources to
growth. The current paradigm based on E. coli is that cells balance supply and demand of amino acids to
maximize growth rate under all growth conditions. These models are important because they have been able
to explain the tradeoﬀ between production of cellular energy vs. production of proteins that is pertinent to
cancer. However, we have obtained experimental results in B. subtilis that directly challenged this E. coli centric
view of growth control. We will thus seek more general principles of cellular resource allocation that
encompass both E. coli and B. subtilis, and ideally beyond bacteria. Finally, we will extend our previous work
on cell-size control to investigate how cells ensure physiological equilibrium when proteins and organelles
partition asymmetrically, which is important in the context of inheritance and cellular aging.
These questions require multidisciplinary approaches from physiology to development of novel technologies.
To this end, we will work with collaborators who are leaders in their research ﬁelds. Furthermore, over a
decade we have been making major eﬀorts to democratize technologies to the research community. We expect
the knowledge and technology that will be generated from our proposed research to open exciting new
research avenues and facilitate other important discoveries in physiology and cell biology.
Project Summary/Abstract Page 6

Public health relevance
Project Narrative Page 7